Membrane remodeling by alpha-synuclein: implications for function and disease

DESCRIPTION (provided by applicant): The control of membrane shape and curvature is essential for all cellular membrane remodeling events and aberrations in this poorly understood process have been linked to a number of diseases. This proposal is based upon the recent discovery that α-synuclein (αS), a protein involved in the pathogenesis of Parkinson's disease, can induce membrane curvature and potently remodel cellular membranes into bilayers tubes, micellar tubes and discs. Membrane and fatty acid interaction of αS is of relevance for the pathological as well as the normal functions of this protein; however the mechanisms by which αS interacts with membranes and fatty acids in health and by which it can disrupt membrane integrity in disease remain poorly understood. The central goal of this proposal is to arrive at a detailed molecular and structural understanding of how αS binds to membranes and how this interaction, in turn, affects membrane structure and function in vitro and in vivo. In order to investigate the mechanisms that allow αS to induce the formation of these remarkably diverse membrane structures, Specific Aim 1 uses a combination of EPR, NMR and cryo-EM based approaches to determine the structures of αS in complex with membrane tubes and discs. Specific Aim 2 investigates how αS can interact with mitochondria and liposomes whose lipid compositions mimic those of cellular membranes. These studies will give a first indication of the extent to which αS can remodel different cellular membranes. This aim will also test whether αS disease mutants or misfolded, toxic αS oligomers can compromise membrane integrity by uncontrolled induction of membrane curvature and whether this effect can be further promoted by N-acetylation. Structural changes will be monitored using EM, EPR and NMR while membrane integrity will be assayed using leakages experiments. In Specific Aim 3, we will test the hypothesis that αS can bind to lipids and fatty acids in similar manners. As part of this aim we will perform structural studies to test whether discs and cylindrical micelles formed with fatty acids have the same structure as those formed with lipids. We will also investigate the mechanism by which free fatty acids can promote the misfolding of αS. Finally, we will investigate the fatty acid-dependent oligomerization of αS within cells. These studies will also address the controversy with respect to αS being a natively unfolded monomer or tetramer in the cell. Collectively, these studies also aim to provide a foundation for understanding αS's membrane related roles in normal physiology and Parkinson's disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: The disruption of a cell's ability to control the shape, integrity and curvature of its membranes can cause a wide range of diseases. The present proposal seeks to understand how -synuclein, a protein that can cause Parkinson's disease, can normally shape membranes in the cell and how this process can go awry in disease. The results will have implications for our understanding and treatment of Parkinson's disease and provide new insights into the basic principles that allow proteins to shape membranes.